IntelliStent: A minimally Invasive, Adjustable Pulmonary Flow Restrictor System for Congenital and Acquired Heart Disease

ABSTRACT
HeartPoint Global’s IntelliStent is the first minimally invasive, adjustable pulmonary flow restrictor developed for
pediatric and congenital heart disease (CHD) patients. Treatments to modify pulmonary flow in the pediatric and
CHD populations are currently limited to open-chest pulmonary artery banding (PAB) and expensive medication
regimens. Both of these treatments have severe limitations, including significant risks of morbidity and mortality,
and have high rates of failure. There is a critical unmet need to develop novel treatments that are both more
effective and less risky than current approaches. Previous attempts to adapt devices designed for adult
cardiovascular treatments have been unsuccessful, largely due to the unique characteristics of pediatric and
CHD patients. IntelliStent is currently developed in a size range suitable for patients 12 years and up, with
successful pre-clinical testing completed that showed no signs of thrombosis in chronic (9.5 month) studies. Re-
engineering the IntelliStent in a size range suitable for neonates and infants would represent the first minimally-
invasive treatment specifically developed for children. This proposal aims to prepare IntelliStent for first-in-human
testing for sizes in patients from birth. Our specific aims are: (1) Downsize the IntelliStent to be suitable for
patients from birth, including preclinical testing; (2) Complete biocompatibility testing as required for regulatory
submission; and, (3) Optimize manufacturing processes for clinical and commercial production. Successful
completion of this proposal would bring to market a novel treatment for pulmonary flow modification and
represent a transformative step in the treatment of pediatric patients with congenital and acquired heart disease.

Public health relevance
NARRATIVE Treatments to modify pulmonary flow in congenital and acquired heart disease populations are currently limited to open-chest pulmonary artery banding (PAB), expensive, often ineffective medication regimens, and mechanical circulatory support or heart transplantation. All of these treatments have severe limitations, including significant risks of morbidity and mortality. There is a critical unmet need to develop novel therapies that are more effective and less risky than current approaches. HeartPoint Global’s IntelliStent is the first purpose-built minimally invasive, adjustable pulmonary flow restrictor developed for congenital and acquired heart disease to meet the needs of patients of all ages from birth to adulthood.